Point-of-Care Multiplexed Immunosuppressant Monitoring

Project Summary
Approximately 24 million Americans require long-term immunosuppressive therapy/treatment, either due to an
autoimmune disease or because they recently had a transplant, solid organ or bone marrow. The goal of immune
suppression is to administer the minimum effective dose to prevent the immune system’s attack on the patient’s
own tissue in the case of an autoimmune disease or prevent organ rejection in the case of a transplant, without
leaving the patient dangerously vulnerable to infection. Research has shown there is a narrow window of
therapeutic concentrations for immunosuppressive drugs in blood that is safely effective for a given patient and
unfortunately, different patients can require dramatically different dosages to reach that optimal level.
Complicating the matter further is the fact that drug levels must be measured at precise intervals after dosing to
account for differences in the rates of metabolism from patient-to-patient. Unfortunately, the current technology
for measuring these drug levels requires large blood draws that are only available in centralized lab facilities. So,
in practice, immunosuppressive drug monitoring is logistically complicated and burdensome, in addition to being
inconvenient and largely inaccessible for patients, who must: 1) arrange transportation to a blood draw clinic or
transplant center, which may be hundreds of miles from home; 2) take a dose and wait around for hours for the
drugs to enter their bloodstream; and/or 3) have several these blood draws. This process is unfeasible for routine
drug monitoring. Electronic BioSciences, Inc. (EBS) proposes to develop a new method, based on the latest
advances in nanopore technology, for the monitoring of immunosuppressive drugs. The advantage of the
developed technology is that it will be as easy to obtain and use as a fingerstick glucose test. This will in turn
enable readily available, routine immunosuppressive drug monitoring for these patients, at hospitals, transplant
centers, outpatient clinics, or even at home. More frequent monitoring of immunosuppressive drug levels at
specific time intervals will result in more accurate dosing, and consequently fewer life-threatening infections
and/or episodes of organ rejection. Until a fast, easy, inexpensive test for immunosuppressive drug monitoring
is developed, patients will be unnecessarily burdened and at risk, and doctors will continue to be in the dark
when trying to correctly dose these drugs.

Public health relevance
Project Narrative Our proposed immunosuppressive drug monitoring technology has the potential to become the “Gold Standard” technique in therapeutic drug monitoring and will revolutionize how researcher/clinicians develop, assess, utilize, and dose immunosuppressants for all organ transplantation and patients suffering from autoimmune diseases. The proposed technology will ultimately result in significantly increased medical response efficiency, improved patient care, and better patient outcomes, all at a reduced cost.